Studies of the initiation and progression of small cell lung cancer using cells derived by differentiation from human pluripotent stem cells

PROJECT SUMMARY
Small cell lung cancer (SCLC) is an especially virulent form of lung cancer that is
only transiently responsive to therapy and kills about 30,000 Americans each year.
Based on a more general interest in understanding why certain kinds of cancers have
characteristic genotypes, we are developing methods for studying the initiation of human
cancers by genetically modifying cells at discrete stages of differentiation after chemical
induction of specific lineages from human embryonic stem cells (hESCs). We have
extended recently published methods for inducing hESCs to form parts of the pulmonary
lineage by perturbing NOTCH signaling and reducing expression of the RB1 gene (one of
the two genes commonly inactivated in SCLC); in this way, we have prepared cultures
with high proportions of pulmonary neuroendocrine cells (PNECs), the putative
precursors of SCLC. Moreover, by also reducing expression of P53, the other gene
commonly inactivated in SCLC, PNEC-containing cultures are able to produce small
tumors resembling SCLC when implanted in immune-deficient mice.
We now propose to expand our studies of this promising model for studying the
origins of SCLC in several ways: by determining the mechanisms by which interference
with NOTCH and RB1 generates PNECs; by exploring several possible assays for the
SCLC-like phenotype we have recently observed; by defining the similarities between the
genetic and physiological features of the SCLCs derived from hESCs and the SCLCs
arising in human patients; and by making induced pleuropotent stem cells (iPSCs) from
normal and tumor cells from patients with lung cancer, especially SCLC, in an effort to
seek genetic risk factors for SCLC. Through these studies, we expect to generate new
information and ideas about risk assessment, prevention, diagnosis, and treatment for
SCLC.
!

Public health relevance
PROJECT NARRATIVE Small cell lung cancer (SCLC) remains a major challenge in public health because of its frequency, its lethality, and the paucity of convenient models for exploring its pathogenesis and potential therapeutic strategies. As part of our efforts to understand how and why certain constellations of genetic changes drive cancer in specialized cell lineages, we have developed early but strong evidence that we can induce from human embryonic stem cells (hESCs) the lung cell type (a neuro-endocrine cell) that has been proposed to initiate SCLC, and we have produced early stage SCLC-like tumors from these cells after genetic changes. We now propose to expand these findings to make an effective model for development of SCLC that can be used to explore new opportunities to diagnose, categorize, treat, and possibly even prevent SCLC more effectively. !